Preventing Retaliatory Gun Violence in Violently Injured Adults: A RCT of a Hospital-Based Intervention

Abstract
In the United States, firearm-related violence has reached epidemic proportions and has become a major public
health problem. To help prevent the high rates of firearm-related deaths, most violence intervention programs
have targeted youth (<18 years old) in the hope to slow the rapid increase of violence seen in early adulthood.
However, most victims of firearm-related violence are adults (>18 years old), and national statistics show young
adults (18-35 years) in particular are the most likely to die from firearm-related violence. It is important to
recognize that this risk is not evenly shared among subpopulations of adults, and it is young African American
men who come from economically disadvantaged communities with high rates of exposure to violence that are
the most vulnerable to firearm-related violence. Unfortunately, they are difficult to engage in community-based
intervention efforts. More recently, however, hospital-based violence intervention programs have become
increasingly popular because of their success at engaging individuals who have suffered a violent injury. Violently
injured adults are not only victims in the present, but 40% will be violently re-injured and 20% will be killed within
5 years; these patients are also 88 times more likely to commit retaliatory violence (Cunningham et al., 2009). It
is clear that these adults are in dire need of effective violence intervention. At Virginia Commonwealth University
(VCU) Health, we have developed Bridging the Gap (BTG), a promising violence intervention strategy that
includes a hospital-based violence intervention, a firearm counseling program, and 6-months of community case
management to victims of violence. BTG was originally developed for violently injured youth and results indicate
it is effective for reducing youth violence. However, it is yet to be established if it is effective for reducing firearm-
related violence in adults. It is also yet to be established if BTG is a cost effective strategy for reducing firearm-
related violence and injury. The present study addresses Objective Two of this funding announcement; to
rigorously evaluate the effectiveness of innovative and promising strategies to keep individuals safe from firearm-
related injuries, deaths, and crime. This research proposal falls under Funding Option B; which supports research
projects that collect new data. The goal of the present study is to assess the efficacy of BTG using a randomized
control trial design in a large sample of 616 adult victims of violence over a 1-year follow-up period. Efficacy will
be assessed using multiple sources of data for firearm-related violence (e.g., criminal arrest records, self-report,
semi-structured clinical assessment of non-convicted firearm-related violence) and firearm-related re-injury and
mortality (e.g., hospital records). To improve our understanding of the impact BTG has on firearm-related
violence, we will test for psychosocial mediators linking BTG to reductions in firearm-related violence. We also
aim to understand what psychosocial vulnerabilities may weaken the impact of BTG on firearm-related violence.
Lastly, a cost-benefit analysis will determine the economic benefits of implementing BTG. Collectively, results
from this study may support the use of BTG as a firearm-related violence intervention for adult victims of violence.

Public health relevance
Project Narrative Hospital-based violence intervention is a unique and effective strategy for targeting difficult to reach and high- risk violently injured patients. This project evaluates Bridging the Gap (BTG), a promising hybrid intervention model that provides a hospital-based violence intervention, a hospital-and community-based firearm counseling program, and 6-months of intensive community case management. It will conduct a rigorous randomized control trial to determine the effectiveness of BTG for reducing firearm-related violence and injury in adult victims of violence, as well as evaluating the economic benefits of BTG to determine its scalability as a firearm-related violence and injury intervention strategy.